Malassezia Immune Responses as Biomarkers of IBD

PROJECT SUMMARY/ABSTRACT
Inflammatory bowel disease (IBD) is the result of a dysregulated inflammatory immune response in the mucosa
of the gastrointestinal tract. The disease is associated with alterations in the permeability of the intestinal epithelia
and changes in the intestinal microbiota. Rather than being a single disease, or two diseases (Crohn's disease
or ulcerative colitis), IBD is increasingly understood as a multifaceted disease that is initiated and exacerbated
by influences such as genetic susceptibility, environmental factors such as diet and smoking, differing immune
responses, and alterations in the intestinal microbiota. A major goal in IBD research and care is to improve
outcomes by targeting disease treatment to an individual patient's specific underlying disease mechanism(s).
Serum antibodies are proving to be a leading biomarker for diagnosing and discriminating IBD patients. The
most commonly used serological antibody markers are Perinuclear Anti-neutrophil Cytoplasmic Antibodies
(pANCA) and Anti-Saccharomyces Cerevisiae Antibodies (ASCA). In this proposal we identify anti-Malassezia
lipase antibodies (AMLAb) as a novel biomarker that identifies a substantial subset of patients with IBD. We
hypothesize elevated AMLAb levels reflect “types” of disease that share underlying mechanisms. To investigate
this, we propose 3 aims that focus on 1) identifying shared clinical and genetic features of IBD patients positive
for AMLAb, 2) assessing the impact of AMLAb on innate immune responses to Malassezia and identifying
features of disease that promote AMLAb, and 3) assessing the link between AMLAb and anti-Malassezia T cell
responses that we have also discovered to be common in these patients and the role of these T cells in the gut
mucosa. Completion of this study will shed light on mechanisms underlying development and persistence of IBD
and will suggest new ways to tailor treatments for these patients.

Public health relevance
NARRATIVE Inflammatory Bowel Disease (IBD) is a chronic inflammatory disease of the intestines that arises from a failure in the ability of the immune system to exist in harmony with microbes of the gut. This study identifies a subset of IBD patients who develop unusual antibodies and T cell responses to the yeast Malassezia and explores what this can tell us about origins and mechanisms of disease using new genomics and proteomics technologies.